Neural Prediction to Enhance Language Outcomes in Children with Cochlear Implant

PROJECT SUMMARY/ABSTRACT
Although cochlear implantation (CI) is the most effective method for managing severe to profound sensorineural
hearing loss, children with CI as a group perform at about 15th percentile of their normal-hearing peers on
language measures. Most intriguingly, their language outcomes are highly variable at the individual level,
despite implantation at a young age. Using pre-surgical brain magnetic resonance imaging (MRI) scans, done
as part of the routine clinical evaluation, as well as AI-enabled analytical methods, our research will construct
neural predictive models to forecast individual-level language outcomes in English- and Spanish-learning
children up to 4 years after surgery. The clinical utility of these models will also be evaluated by investigating
the extent to which the models' prediction is associated with the degree to which a child responds to a program
of intensive communication treatment. We hypothesize that during the 4 years immediately after surgery,
young children with CI follow three stages of language development: 1) global attention to spoken language as
the child acclimatizes to electric auditory input about language, 2) encoding of phonological patterns with
sufficient information to develop auditory-based lexical representations, and 3) development of spoken
language syntax to communicate orally in longer utterances. We also hypothesize that the integrity of brain
networks associated with higher-order cognitive, auditory and syntactic processing differentially contributes to
language outcomes across these three stages in monolingual English-learning children with CI (Aim 1). We
further hypothesize that these networks are largely invariant for typologically similar languages during the first
stage, but that the contribution of the auditory network would be prolonged and require higher-order cognitive
networks to an even greater extent to language outcomes for Spanish-English bilingual children with CI (Aim 2).
As part of our current R21 project, we have developed a standardized clinical evaluation and follow-up protocol
across different CI centers that will facilitate the investigations required to achieve Aims 1 and 2. Aim 3
concerns the interaction between neural prediction of outcomes and behavioral treatment. The main CI center
of this project will enroll monolingual English-learning children for an intensive, Parent-Implemented
Communication Treatment (PICT) program, which is the only treatment program to date whose effectiveness
has been supported by a randomized controlled trial. We will evaluate whether neural prediction of language
outcomes is inversely related to the degree of language gains from PICT. Specifically, we hypothesize that the
more severe the predicted language impairment based on our neural predictive algorithms, the more the child
could benefit from PICT. Our translational research program will advance the field of communication disorders
in technological, theoretical and clinical innovations. It will be among the first to demonstrate that a predict-to-
prescribe approach to holistically treat hearing loss is feasible, cost-effective and can lead to optimization of
language outcomes of all children with CI.

Public health relevance
PROJECT NARRATIVE Language performance of children with cochlear implants (CI) lags behind that of normal-hearing children, and is highly variable. Our proposed study seeks to use pre-surgical brain MRI to predict post-surgical language outcomes in English- and Spanish-learning children with CI, and will evaluate whether neural prediction would improve outcome by identifying those children requiring a more intensive program of language habilitation.